Myobacterium tuberculosis Phenylalanine Synthesis as a Novel Drug Target

PROJECT SUMMARY / ABSTRACT
Metabolic pathways that Mycobacterium tuberculosis (Mtb) requires for growth in lab culture conditions and
that are highly vulnerable to inhibition have been proposed as novel drug targets. Amino acid biosynthetic
pathways represent promising drug targets because they are essential for Mtb growth but are absent in
humans. However, we do not yet know which of these pathways Mtb requires during infection or how their
inhibition influences susceptibility to existing antibiotics. The overall objective of this exploratory proposal is to
determine the potential of phenylalanine (Phe) biosynthesis as a novel anti-tubercular drug target. The central
hypothesis is that inhibition of Mtb Phe synthesis disrupts multiple central metabolic pathways to cause death
of Mtb and enhance susceptibility to existing antibiotics. Preliminary data show that Mtb starved for Phe die in
vitro and that a Phe auxotroph is rapidly cleared from acutely infected mice. Aim 1 will develop Mtb strains that
conditionally express enzymes in the Phe biosynthesis pathway. These strains will be used in macrophage and
mouse infection models to determine the extent to which Mtb requires Phe synthesis during infection and how
Phe synthesis inhibition influences efficacy of existing anti-tubercular drugs. Aim 2 will use transcriptomic and
metabolomic analyses of Phe-starved Mtb to identify the metabolic changes and stress responses induced
upon inhibition of Phe synthesis. The proposed research is expected to be significant because it will establish
Phe synthesis as a promising target for development of new drugs to treat tuberculosis and enable future high-
throughput screens to identify small molecules that inhibit Phe synthesis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because new drugs are needed to treat tuberculosis (TB), which sickens and kills more people worldwide each year than any other bacterial infection. The proposed research is relevant to the mission of NIAID to support basic research in infectious diseases because it will generate fundamental knowledge on the extent to which Mycobacterium tuberculosis relies on synthesis of the amino acid phenylalanine during infection, which can be applied to develop new TB treatments targeting phenylalanine synthesis.